QUINAPRIL AND LOSARTAN IN FIBRIOLYTIC BALANCE

Test the effectiveness of a new treatment for patients with rheumatoid arthritis. Anti-TNF Chimeric Monoclonal Antibody is a biological product which acts to inhibit the action of tumor necrosis factor alpha, a major mediator of inflammation in rheumatoid arthritis. We are in the recruitment and enrollment phase.